Fellowship in Geriatric Mental Health

Project Summary
This is an application for a 5-year renewal of the T32 Fellowship Program in Geriatric Mental Health at the
University of California San Diego (UCSD). As the population ages, the demand for independent investigators
in geriatric mental health will continue to increase. Over the last 15 years, we have trained 71 T32 trainees
including 40 postdoctoral Fellows, 14 predoctoral Fellows, and 17 medical and pharmacy students. This T32
program, continuously funded since 1994, is part of a larger research training program within UCSD’s Division
of Geriatric Psychiatry. It is also affiliated with the UCSD Center for Healthy Aging, Sam and Rose Stein Institute
for Research on Aging, and UCSD’s Clinical and Translational Science Award (CTSA). Over the past 5 years,
68% of our predoctoral and postdoctoral trainees have been women, 37% have been people of color, and 16%
have been from Under-Represented Minority (URM) ethnic groups. All have completed at least two years of
Fellowship training or are still in training, and all are continuing in full-time academic activities. All trainees with
at least one year in the program have published multiple peer-reviewed papers. Our postdoctoral trainees have
obtained 5 K awards or VA Career Development Awards in the past 5 years, and previous Fellows have obtained
funding from NIH, VA, Department of Defense, as well as support from various foundations. We place major
emphasis on career development, both for mentees and mentors. The Fellowship program includes individual
mentoring along with experiential training in team science, complemented by didactic activities. A personalized
Individual Development Plan (IDP) is created with each trainee early in the course of the Fellowship. Writing and
statistical skills enhancement, guidance on balancing personal and professional obligations, and exposure to
cross-disciplinary co-mentors and collaborators characterize our program. This renewal application proposes to
support 5 postdoctoral Fellows (optimally, a combination of PhDs, MDs/MD-PhDs, and PharmDs), 2 predoctoral
students (in clinical psychology or neuroscience), and 2 summer research slots for pharmacy students annually.
Over the next 5 years, we will increase our focus on technology and engineering in aging and mental health,
including mobile health and data science technologies to improve assessment, treatment, and service delivery
for older adults with psychiatric illnesses. We will also continue to emphasize translational and basic
neuroscience, positive psychiatry, physician and pharmacist scientists, diversity of trainees, and research on
training. We have developed a strong plan for evaluation of the training process including short-term,
intermediate-term, and long-term outcomes, including research productivity for Fellows and professional
advancement for mentors.

Public health relevance
Project Narrative This T32 training program will facilitate the development of a diverse and highly trained workforce that will ultimately assume leadership roles related to the nation's biomedical and behavioral research agenda. More specifically, the program will train researchers with expertise in geriatric mental health to help meet the needs of our rapidly aging society.